Developing ER Stress Chemical Modulators as Neuroprotectants for Glaucoma

PROJECT SUMMARY
Glaucoma, the most common worldwide cause of irreversible blindness, is characterized by progressive
dysfunction and death of retinal ganglion cells (RGCs) and degeneration of optic nerve (ON). There is a
significant unmet clinical need for neuroprotectants. Our previous studies of ON traumatic injury and glaucoma
demonstrated that axon injury induce neuronal endoplasmic reticulum (ER) stress in RGCs. We were able to
protect the injured RGC somata and axons if we blocked the detrimental effects of ER stress by manipulating
two key downstream molecules in opposite ways: a) deletion of CCAAT/enhancer binding protein homologous
protein (CHOP), and/or b) activation of X-box binding protein 1 (XBP-1). Using complimentary cell-based high
throughput screening (HTS) of small molecule libraries, we identified multiple series of chemical modulators of
ER stress (CHOP inhibitors and XBP-1 activators), which are promising neuroprotectant candidates. We will
further optimize these chemical ER stress modulators, determine their in vivo efficacies in clinically relevant
mouse glaucoma models, and illustrate their mechanism of action. We expect the results through these studies
will identify preclinical drug candidates and provide essential information for clinical application of ER stress
modulation, and establish translational strategies for safe and effective clinical management of glaucoma
patients.

Public health relevance
PROJECT NARRATIVE Neuroprotectant is urgently needed for glaucoma treatment. The proposed experiments are built on solid previous results and promising preliminary data to advance lead compounds into optimized preclinical drug candidates. In vivo efficacies of these novel treatments will be further determined at both bulk and single-cell levels using our newly developed techniques in inducible and reversible ocular hypertension glaucoma mouse models.